GDMCC Career Enhancement

Training the next generation of physician scientists in rare disease research is essential for ongoing discovery
and clinical care for those afflicted with primary immunodeficiency, primary ciliary dyskinesia, and a host of
other chronic suppurative respiratory diseases. The career enhancement core for the Genetic Disorders of
Mucociliary Clearance Consortium (GDMCC) is poised to meet this challenge with a structured plan to recruit,
involve, mentor, train, and mold trainees and early career investigators into adept and successful rare disease
researchers.
The overall goal of the GDMCC career enhancement core is to provide trainees with an outstanding
environment to acquire the research, clinical, and professional skills needed to lead productive academic
research careers in rare airways disorders. To accomplish this, the core will provide state-of-the-art learning
opportunities for trainees, while leveraging and building with our partner stakeholder organizations to ensure
academic advancement. Four specific and structured aims underpin this core program: (1) Engaging a diverse
group of GDMCC and partner organization trainees in clinical and translational research involving rare
respiratory disorders, (2) Providing trainees with unique learning activities and networking opportunities in rare
disease that are not available in currently funded training programs, (3) Providing structured mentoring and
oversight of trainees and early career investigators, with regular benchmarking of their academic progress, and
(4) Providing authorship opportunities on major research publications and mentored leadership positions on
pilot research projects in rare respiratory disease. These aims will allow the GDMCC to successfully train the
next generation of rare respiratory disease researchers. The structured plan behind each aim will equip
trainees and early-career investigators with a robust academic foundation upon which they can build careers of
research and innovation to benefit patients suffering from rare respiratory diseases.